Project 2: Optimizing patient selection and deintensified therapy for human papillomavirus positive (HPV+) oropharyngeal cancer (OPC)

PROJECT SUMMARY – PROJECT 2
Human papillomavirus positive (HPV+) oropharynx cancer (OPC) is a national and global health issue.
Because HPV+ OPC has very good survival outcomes, the long-term toxicity of current treatment, typically
combined chemotherapy and radiation (CRT) is devastating. Trans-oral robotic surgery (TORS), a surgical
technique pioneered by Dr. Ferris and others, has been studied to reduce toxicity of HPV+ OPC treatment,
culminating in ECOG 3311, a prospective trial of TORS followed by risk-adapted adjuvant therapy depending
on tumor and nodal pathology. Despite excellent survival in this trial (ASCO 2020, Abstract #6500), slightly
over 30% of patients were found to have high risk neck disease (HRND), characterized by gross extranodal
extension (ENE, >1mm) or ≥5 positive lymph nodes, which mandated the use of adjuvant, high dose CRT, an
intensification of treatment where de-intensification is the goal. However, as ~70% of patients were candidates
for de-intensification, interest remains high in TORS as a strategy, particularly if patients with HRND can be
identified prior to surgery. To this end, and with the assistance of Core A and Core B we have identified 40
patients from ECOG 3311 enrolled from HCC (as the highest accruing site) and comprehensively genomically,
transcriptomically and radiomically profiled their tumors. This preliminary data allowed us to generate a four-
gene mutational signature present in ~80% of patients with HRND, with similar findings in the Head and Neck
cohort from the Cancer Genome Atlas. Additionally, we observed a profound immune repression in tumors
from patients with HRND. In this Project we expand our analysis to an additional 200 HPV+ OPC patients we
have identified in the organ specific database (OSD in Core A) for which tissue is already available (Core B)
and then validate our signature in over 200 additional tumors from ECOG 3311. Additionally, we plan to
recapitulate the mutations from our signature, as well as others identified by our co-I Dr. Burtness, which
appear to be associated with immune infiltrate in HPV+ OPC, in pre-clinical models to identify potential drivers
of immune infiltrate. Finally, to address the management of HRND, we will conduct a clinical trial HCC 18-034
(PI: Ferris) designed for this SPORE project examining the combination of TORS, lower dose RT and anti-PD-
1 therapy in patients with HRND to improve toxicity and quality of life compared to chemoradiation in both a
newly added control arm based on reviewer feedback as well as ECOG 3311. The effect of tumor mutation,
immune infiltrate, and peripheral blood IFN signature on outcome in this trial will also be examined.
Success of this project will produce: 1) a validated and immediately applicable predictive signature for
HRND; 2) an explanation for the repressed immune infiltrate seen with HRND; 3) quality of life/toxicity
comparisons and biologic correlatives from a novel deintensification trial in HRND.

Public health relevance
PROJECT NARRATIVE − PROJECT 2 Treatment of human papillomavirus (HPV) positive squamous cell carcinoma of the oropharynx (OPC) is highly toxic; however, the use of Trans-Oral Robotic Surgery (TORS) could provide improvements in toxicity if patients with high risk neck disease (HRND) could be identified prior to surgery, and treated with other modalities. This project: 1) subjects clinical samples from over 400 patients with HPV positive OPC treated with TORS in two separate cohorts, including ECOG 3311, to comprehensive genomic, transcriptomic and radiomic analysis to examine a preliminary signature for predicting HRND, coupled with 2) in vivo analysis of mutations already identified as associated with HRND and immune infiltrate and 3) quality of life, toxicity and biospecimen analysis of a prospective trial combining TORS, RT and immunotherapy in this disease. The overarching goal of this Project is to truly apply precision oncology to HPV+ OPC.